ANTI TNF CHIMERIC MONOCLONAL ANTIBODY IN PATIENTS WITH RHEMATOID ARTHRITIS

This study will evaluate the efficacy and safety of chronic treatment with cA2, an anti-TNF chimeric monoclonal antibody in combination with methotrexate in subjects with active rheumatoid arthritis despite treatment with methotrexate.